Delineating mechanisms underlying the enhanced stability and functionality of CD2- KO Tregs and chimeric antigen receptor (CAR) Tregs and their application in xenotransplantation

PROJECT SUMMARY
Regulatory T cell (Treg) therapy has been widely investigated for control of immune responses in different models
of autoimmunity and transplantation. Despite promising results in using Tregs and chimeric antigen receptor
(CAR) Tregs for tolerance induction, there are still major concerns regarding the plasticity of Tregs and the effect
of T cell-depleting conditioning regimens on these cells that need to be addressed before their clinical application.
We have discovered that CD2-KO Tregs and CAR Tregs are not only resistant to a conditioning regimen that
includes anti-CD2 antibody (siplizumab), but also have increased FOXP3 expression and Treg functionality in
vitro and in vivo. CD2 is a costimulatory molecule that is present in all T cells, including Tregs. Potential direct
or indirect link between CD2 signaling and FOXP3 is not known. Our preliminary data show that CD2-KO Tregs
have increased mTORc1 activity, glycolysis and mitochondrial respiration. We hypothesize that metabolically-
active CD2-KO Tregs generate metabolites that through histone modification or post-translational modifications
increase FOXP3 levels. In Aim 1, we will address these hypotheses. We will study CD2+ and CD2-KO Tregs at
the genome, epigenome, transcriptome and protein levels and evaluate their metabolism and signaling
pathways. In Aim 2, we will explore the translational aspects of this discovery in xenotransplantation setting. We
have developed and validated a CAR against a universal pig antigen (class-I swine leukocyte antigen (SLA))
and have shown that SLA CAR Tregs harbor higher suppressive capacity in suppressing anti-pig immune
responses in vitro as compared to polyclonal Tregs. We hypothesize that CD2-KO SLA CAR Tregs resist
conversion to effector T cells and protect transplanted pig organs in an antigen-specific manner. We will evaluate
the resistance of CD2-KO SLA CAR Tregs to conversion in inflammatory conditions and also the efficacy of CD2-
KO SLA CAR Tregs in preventing the rejection of pig islets in a humanized mouse model of xeno-islet
transplantation. Taken together, this work can potentially lead to the development of safer and more efficient
Treg-based immunotherapies. Mechanistic studies could uncover molecules and/or signaling pathways involved
in determining the fate/function of Tregs, targeting of which could alter the immune balance toward tolerance.

Public health relevance
PROJECT NARRATIVE We have discovered that removal of CD2 increases FOXP3 expression and immunoregulatory functions of regulatory T cells (Tregs). We propose some mechanistic studies to uncover molecules and/or signaling pathways involved in determining the fate of Tregs, targeting of which could alter the immune balance toward tolerance. Also, using a pig-specific chimeric antigen receptor (CAR) that we have developed, we will explore the translational aspects of this discovery in humanized mouse model of xeno-islet transplantation (CD2-KO anti pig CAR Treg therapy).